Role of RhCMV in shaping the SIV proviral landscape

Project Summary/Abstract
The main obstacle to curing HIV-1 infection is a reservoir that consists of resting memory CD4 T cells whose genomes
contain inducible and replication-competent HIV-1 proviruses. Decay of the reservoir is slow and requires lifelong
antiretroviral therapy (ART). It has become increasingly clear that the predominant mechanism sustaining HIV-1 persistence
during ART is the physiologic proliferation of latent-infected memory CD4 T cells. Infected CD4 T cells can proliferate
without producing virus, the result of which will lead to daughter cells harboring expanded HIV-1 proviral clones that share
identical sequence and host integration sites. The rate of expansion among distinct proviral clones in this setting however is
not equal. In some individuals, upwards of 30% of proviruses sampled can belong to populations that are highly clonally
expanded, a mechanism consistent with clonal proliferation by antigen encounter. Establishing a link between particular
antigens and the degree to which they independently contribute to HIV persistence, however, is an unresolved question.
Cytomegalovirus (CMV) is a latent betaherpesvirus that while asymptomatic in immunocompetent hosts, persistently
stimulates the memory T cell pool. Persons living with HIV are near universally coinfected with CMV. In this project, we
have assembled a multidisciplinary team of investigators to directly assess the degree to which chronic antigenic stimulation
by CMV (i) promotes proliferation of the memory CD4 T cell pool (ii) contributes to clonal diversity and size of the HIV-
1 reservoir during ART and (iii) impacts the time to viral recrudescence when ART is interrupted. Specifically, we will
utilize the well-established model of ART-treated SIV-infected rhesus macaques to examine these questions by a dual
approach. The first will exploit availability of pathogen-free, rhesus CMV (RhCMV)-naïve rhesus macaques (RMs) to
compare SIV reservoir dynamics in the presence or absence of CMV. The second will assess measures of SIV persistence
when CMV replication is blocked pharmacologically with antiviral Cidofovir. Critical to our aims are that we will
interrogate SIV proviral DNA at multiple longitudinal timepoints, in multiple tissues, and with several assays that inform
both quantitative and qualitative aspects of the SIV reservoir. We believe that the comprehensive, highly synergistic, and
rigorously controlled studies we propose will (i) identify an immunodominant target that promotes turnover of memory
CD4 T cells during ART and by extension, persistence of the HIV-1 reservoir and (ii) provide a rationale to employ recent
well-tolerated FDA-approved CMV antivirals as a means to accelerate HIV-1 clearance.

Public health relevance
Project Narrative Despite the profound benefit of antiretroviral therapy (ART) to patient quality of life, HIV-1 remains an incurable infection. Our proposed studies aim to examine the role of Cytomegalovirus (CMV) in promoting the proliferation of latent HIV-1 infected memory CD4 T cells. In the long-term, the proposed studies will hope to provide a rationale for current well- tolerated CMV antivirals recently approved by the FDA to accelerate clearance of the latent HIV-1 reservoir.